The Impact of Pulmonary Influenza Infection on the Pathogenesis of Myocardial Infarction and Heart Failure

Respiratory infections like those caused by influenza A virus (IAV) represent a prominent cause of morbidity and
mortality globally. Outside of its well-characterized effects in the lung, IAV infection accelerates cardiovascular
disease, leading to an approximate six-fold increase in the likelihood of myocardial infarction (MI). This strongly
suggests an essential pulmonary-cardiac immunological crosstalk during infection. Despite these observations,
very little is known mechanistically as to how IAV disrupts cardiac homeostasis, damages the heart and promotes
cardiovascular disease pathogenesis. Using a combination of innovative mouse models of respiratory infection,
myocardial infarction (MI) and heart failure (HF), Dr. Jeffrey Downey will comprehensively probe the hypothesis
that IAV translocates from the lung to the heart and induces an antiviral response that damages the heart, leaving
it more susceptible to disease. Elucidating how exactly IAV accesses and impacts the heart will not only unravel
a novel pulmonary-cardiovascular immunological axis, but will also serve to address an unmet clinical need in
countering infection-induced cardiovascular events. This proposal is composed of three aims. In the first aim,
we will study the effects of pulmonary IAV infection on the heart, building on preliminary data that show (1)
elevated troponin in humans and mice and (2) impaired heart function in mice after infection. We will determine
which cells become infected and examine how the virus causes damage, expanding on our preliminary data that
suggest direct type I interferon (IFN-I) signaling on cardiomyocytes causes the decline in cardiac function. In the
second aim, we will investigate how underlying infection alters the pathogenesis of MI and influences its severity
using a unique approach that combines our IAV mouse model with two types of MI. We will moreover genetically
target IFN-I signaling in cardiomyocytes and utilize cutting-edge CRISPR/Cas9 technologies to minimize MI risk
following infection. Finally, in aim three during the independent phase, Dr. Downey will interrogate the
bidirectional influence of anti-IAV immunity on the development and progression of HF, by testing if established
HF promotes susceptibility to IAV and if previous infection accelerates HF. Collectively, these studies will greatly
expand our understanding of inter-organ inflammatory communication during infection and disease, while also
providing greatly needed therapeutic targets. Dr. Downey will primarily conduct this research within the
Cardiovascular Research Institute at the esteemed Icahn School of Medicine at Mount Sinai under the primary
mentorship of Dr. Filip Swirski, a world-renowned investigator of cardio-immunology, and co-mentorship by Dr.
Michael Schotsaert, a leader in virology, microbiology, and vaccinology. Dr. Downey has additionally assembled
an elite Advisory Committee comprised of Dr. Mandy Van Leent, a pioneer in non-invasive multiparametric
imaging and immunotherapy, and Dr. Deepak Bhatt, the leading expert in interventional cardiology and
cardiovascular clinical trials. Together, these mentors will help Dr. Downey foster his own successful research
program and facilitate his career as an independent biomedical investigator.

Public health relevance
Narrative The aim of this project is to expand our understanding of how pulmonary influenza A virus infection influences the health of the cardiovascular system. Using innovative models of human disease, we will explore how inflammation induced by influenza infection alters cardiovascular homeostasis; enhances myocardial infarction risk; and affects the initiation and progression of heart failure over life. Results from this study will not only uncover novel pulmonary-cardiac inflammatory cross-talk during infection, but also provide innovative means to target immune axes following infection to protect the heart and mitigate cardiovascular risk.